A High Throughput Assay for MHC-Peptide Interactions

DESCRIPTION (provided by applicant): There is a need for new proteomics technologies to enable multiplexed assays of immune system response. We aim to develop a novel technology for this application that is based on simultaneously measuring the binding of many customizable in silico-defined peptides. This technology could be applied to identify epitopes from pathogens, autoantigens, allergens or tumors for use in vaccine design and monitoring of immune responses.

Public health relevance
This proposal aims to establish a novel, high-throughput tool that can identify the particular components of a given pathogen, autoantigen, allergen or tumor that are best presented to the immune system by an individual. This tool could be used for vaccine design and monitoring of immune responses. More generally, the technology in this proposal would enable a novel approach for measuring inter-individual variation in the immune response.